Establishment of a Bat Resource for Infectious Disease Research

Bats are reservoirs, or suspected reservoirs, of many zoonotic viruses, including SARS, SARS2 and MERS coronaviruses, and Ebola, Sudan and Marburg viruses. Little is known about how these viruses circulate in their bat reservoirs, principally because of a lack of bat colonies that can be used for the development of experimental infection models. To address this deficiency, we have established a breeding colony of Jamaican fruit bats (Artibeus jamaicensis) and will establish a breeding colony of Egyptian fruit bats (Rousettus aegyptiacus) as a resource for investigators who study these viruses. Egyptian fruit bats are the principal natural reservoir of Marburg virus and Sosuga virus, both of which are human pathogens. Jamaican fruit bats are the best studied bat model for infectious diseases and we have demonstrated that they are a model organism for Ebola and Marburg virus infections. We will generate primary cell cultures and immortalized cell lines from various tissues from these species and freeze live bone marrow that will be useful for studying how these viruses infect bat cells, and how the viruses may modulate the innate immune responses. Recombinant cytokines will also be produced for the research community, including those for generating macrophages and dendritic cells (GM-CSF, Flt3L), T cells (IL-2, IL-7, IL-15) and for in vivo modulation of the adaptive immune response (IFNγ, IL-4). Moreover, we will generate monoclonal antibodies for use in cytokine detection assays and flow cytometry of immune cell subsets and in vivo neutralization. Finally, we will perform experimental infection studies of with ebolaviruses, Sosuga virus, and the SARS- related coronaviruses, BANAL-52 and BANAL-236, to study the infection kinetics, virus distribution and transcriptomic, proteomic and metabolomic profiles of bats during infection, and escalation and resolution of the immune response. Tissues, cells and sera from naïve and infected bats will be archived in a biobank that will be made available to the research community upon virus inactivation. The establishment of this resource will lead to a better understanding of how bats host highly pathogenic viruses without disease and may shed light on events that increase spillover risks to humans. In turn, this information could lead to development of mitigation strategies to prevent future virus spillover and uncover new strategies for therapeutic treatment of coronavirus and Nipah virus diseases.

Public health relevance
Bats are reservoirs of several human pathogenic viruses with pandemic potential, including coronaviruses and filoviruses, yet they do not develop disease when infected with these viruses. We will establish a resource of Jamaican fruit bats and Egyptian fruit bats for use by researchers who study viruses that infect bats. We will also develop cell lines and reagents for use in bat research, and perform experimental infection studies in bats to determine how they can host these viruses without disease, which may lead to novel approaches to treating humans infected with these viruses.